Crisis migration and youth mental health: The moderating influences of culture, context, and community

PROJECT SUMMARY/ABSTRACT
Crisis migration has increased significantly over the last decade, with urgent calls within the United
States (U.S.) to develop better programs and policies to support newly immigrated youth and their families
seeking refuge.1 In recent years, patterns of migration from Venezuela to the U.S. have dramatically increased,
as Venezuela continues to grapple with humanitarian, socio-political and economic crises.3,4,15 Many migrant
youth from Venezuela have likely been exposed to dire circumstances (i.e., food insecurity) in their country,17,18
only to be met with further stressors such as, language barriers, acculturation stress and prejudice,6,20 upon
resettling in the U.S. Given the unique pre and post migration experiences and stressors that can occur, it is
critical to understand how to best support the mental health and wellbeing of newly arrived families from
Venezuela.
The proposed project leverages an existing NIMHD-funded R01 (MD015920) grant examining pre and
post migration factors impacting adjustment in recently arriving Venezuelan families seeking refuge in the U.S.
The mixed-methods dissertation project at the center of this R36 proposal seeks to understand the mental
health impacts of crisis migration on recently arriving Venezuelan youth, and to examine key risk and protective
factors that moderate these mental health impacts. Aim 1 will examine links between youth crisis migration
experiences in Venezuela and subsequent youth anxiety and traumatic stress symptoms in the U.S. and Aim 2
will evaluate the extent to which cultural, community, and contextual factors (e.g., ethnic pride, neighborhood
context) may impact the mental health effects of crisis migration (N=300). Building on these quantitative
analyses, Aim 3 employs a qualitative approach to explore caregivers’ perspectives in their own voice (N=15)
on individual youth, family, and community protective strengths, as well as caregiver reflections on
intersections between socio-political structures and their children’s mental health. Findings from this proposed
project can help inform best practices for supporting Venezuelan migrants, as well as other youth populations
in the U.S. adjusting in the aftermath of crisis migration.

Public health relevance
PROJECT NARRATIVE Crisis migration has surged across the world, with an increasing number of populations forced to flee their home countries to escape violence, persecution, political unrest, and/or socio-economic turmoil, Venezuela, for example, has seen millions of families leave the country to escape an unstable humanitarian crisis and resettle in the United States (U.S.).3 The proposed project seeks to understand the mental health effects of such crisis migration on youth, as well as the extent to which various cultural strengths and community factors may moderate and mitigate these mental health risks. To inform services and supports, a mixed-methods approach will be used to assess the degree to which crisis migration experiences impact subsequent anxiety and traumatic stress symptoms in youth recently arriving to the U.S. from Venezuela, as well as caregivers’ perceptions of their children’s identity-related strengths and supportive characteristics of their receiving communities that can optimize wellbeing and promote resilience.